In vivo single-cell analysis of Alzheimer's disease-associated regulatory elements

PROJECT SUMMARY
Treatment options for Alzheimer’s disease (AD) have been elusive, in large part because the molecular and
cellular mechanisms underlying AD pathogenesis remain unclear. Recent studies have identified various
cis-regulatory elements (CREs) associated with AD, including 75 genomic regions identified by genome-wide
association studies (GWAS) and thousands of genomic regions with altered chromatin architecture in
postmortem brains from individuals with AD. These CREs are thought to influence AD pathogenesis by
affecting gene regulation in a cell type-specific and age-dependent manner. Therefore, it is crucial to study how
AD-associated CREs orchestrate gene expression at single-cell resolution. To achieve this, we propose a
scalable platform, single-cell Massively Parallel Reporter Assays (scMPRA), to investigate how AD-associated
CREs regulate gene expression across different cell types. The scMPRA platform combines high-throughput
sequencing and barcoding technology with single-cell RNA-sequencing to simultaneously assess the
regulatory effects of thousands of CREs in a cell type-specific manner. We will apply scMPRA to in vivo mouse
brains from two well-established AD models, which recapitulate both shared and distinct pathological aspects
of AD, along with age-matched littermate controls. This will allow us to examine the regulatory effects of CREs
within an intact physiological context, accounting for natural cellular interactions and aging processes, thereby
offering new insights into the genetic architecture of AD. Upon completion, we aim to establish a novel genomic
toolbox for identifying cell type-specific CREs, pinpoint cell types critical for aging and AD pathogenesis, and
understand gene-environment interactions in the context of AD.

Public health relevance
PROJECT NARRATIVE Alzheimer's disease (AD) is an age-related brain disorder without effective treatments to date, largely due to the limited understanding of the precise molecular mechanisms underlying neuronal- and glial-specific gene regulation changes associated with the disease. We will develop a new method to study how AD-associated cis-regulatory elements regulate gene expression across different brain cell types and how their dysregulation contributes to AD pathogenesis. The knowledge and experimental tools generated by our studies may facilitate the development of novel diagnosis/prognosis biomarkers and therapeutics for AD.